Characterizing the role of MSRA in pancreatic tumorigenesis

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDA) is an aggressive malignancy that remains largely incurable. The KRAS
oncogene is mutated in 95% of PDAs and acts as a potent driver of PDA growth and maintenance. Oncogenic
KRAS induces a profound rewiring of metabolic pathways that are essential for PDA growth. Interestingly, this
rewiring generates metabolic by-products, including reactive oxygen species (ROS), that can potentially oxidize
macromolecules, resulting in genomic instability and toxic cellular damage. However, in addition to these
indiscriminate activities, ROS can also initiate redox signaling through oxidative post-translational modifications
of proteinaceous cysteines, such that toggling between the reduced and oxidized states of cysteine constitutes
a “redox switch” that can regulate the structure and/or function of a protein. Indeed, using our pancreatic
organoid model (Cell, 2015), we previously showed that oncogenic KRAS promotes pancreatic tumorigenesis in
part by regulating the cyclic reduction/oxidation of cysteines on select proteins involved in the translation
machinery (Cell, 2016), thereby promoting protein synthesis (Cell, 2016), glucose metabolism, and tumor growth
(Nature Communications, 2019). While cysteine is well-recognized for its susceptibility to oxidation, it is often
not appreciated that methionine, the other sulfur-containing amino acid, can be readily oxidized to methionine
sulfoxide, and reduced by the oxidoreductase, methionine sulfoxide reductase A (MSRA). Using a tissue
microarray of patient-derived pancreatic tumors and adjacent normal tissues, we observed a stage-dependent
decrease in MSRA protein expression in tumor tissues. Consistently, acute knockout of murine MSRA using
CRISPR/Cas9 in premalignant pancreatic organoids provides a migratory advantage in vitro and in vivo. Thus,
we hypothesize that redox signaling through oxidative post-translational modification of methionine
residues (Met-oxPTM) represents an unexplored mechanism that supports pancreatic metastasis.
Herein, we propose to i) define the mechanism regulating MSRA expression in PDA, ii) characterize the
functional and clinical significance of oxidized methionine peptides in PDA metastasis, and iii) define and
characterize targetable vulnerabilities created by Met-oxPTM in PDA cells.

Public health relevance
PROJECT NARRATIVE The current proposal “Characterizing the role of MSRA in pancreatic tumorigenesis” will use organoid models, chemical proteomics, and biochemical tools to elucidate fundamental aspects of redox metabolism in pancreatic cancer. We anticipate our results will establish mechanistic understanding and therapeutic inroads for methionine-based redox signaling in pancreatic cancer.